Mechanisms Underlying the Pathogenesis of SEL1L-HRD1 ERAD Disease Variants

Mechanisms Underlying the Pathogenesis of SEL1L-HRD1 ERAD Disease Variants
ABSTRACT
Our laboratories are interested in the physiological role of endoplasmic reticulum (ER)-associated protein
degradation (ERAD), a principal mechanism for the recruitment and retro-translocation of misfolded ER
proteins for cytosolic proteasomal degradation. The SEL1L-HRD1 protein complex represents the most
conserved branch of ERAD, where single-span transmembrane protein SEL1L functions as an obligatory
cofactor for the multi-span transmembrane protein E3 ligase HRD1. Using mouse models, recent evidence
has demonstrated pivotal roles of SEL1L-HRD1 ERAD in many physiological processes such as energy
metabolism, water balance and innate immunity; however, no disease mutant of SEL1L or SYVN1 (encoding
HRD1 protein) has been identified in humans. In collaboration with three clinical geneticists in Saudi Arabia,
France and Italy, we have identified three bi-allelic missense point mutations in SEL1L (G585D, M528R) and
SYVN1 (P398L) in three families, all of whom exhibit similar developmental and neurological defects, including
global developmental delay and severe intellectual disability. However, the causality of these novel
SEL1L/SYVN1 variants and their underlying mechanisms remain largely unclear. In the preliminary data of
this application, we found that a mutation of SEL1L at Serine 658 to Proline (S658P) identified in Finnish
hound with early onset cerebellar ataxia caused early-onset ataxia in mice due to the disruption of the
interaction between SEL1L and HRD1. Furthermore, human SEL1L G585D variant attenuates the interaction
between SEL1L and substrates. We hypothesize that these variants are hypomorphic disease-causing
mutations in humans by attenuating SEL1L-HRD1 ERAD function. Using knock-in mouse and cell models
powered by state-of-art imaging and high throughput techniques, we will accomplish the following two Aims:
(1) Determine the causality and pathophysiological significance of human SEL1L and SYVN1 variants in vivo;
and (2) Delineate the molecular mechanism underlying the pathogenicity associated with human SEL1L and
SYVN1 variants. This study will not only transform our understanding of the importance of SEL1L-HRD1
ERAD in humans, but provide future framework for targeting SEL1-HRD1 ERAD therapeutically in humans.
RELEVANCE TO HUMAN HEALTH: This study represents the first attempt to identify and establish disease-
causing mutations of SEL1L-HRD1 ERAD in humans. It will significantly advance our understanding of the
importance of SEL1L-HRD1 ERAD in health and disease.

Public health relevance
NARRATIVE Endoplasmic reticulum (ER)-associated degradation (ERAD) is the principal mechanism for the recruitment and retro-translocation of misfolded ER proteins for cytosolic proteasomal degradation. After spending over 15 years in studying the most conserved ERAD branch – the SEL1L-HRD1 protein complex – using mouse models, we recently identified three missense point mutations in the SEL1L and SYVN1 (encoding the HRD1 protein) genes in six patients belonging to three families – all of whom exhibit similar devastating neurological defects starting at infancy. In this application, we will test the hypothesis that these variants are hypomorphic disease-causing mutations in humans by attenuating SEL1L-HRD1 ERAD function.